Ameliorating Respiratory Neuromotor Dysfunctions in Aging and Alzheimer's Disease

ABSTRACT
The studies in the proposal are focused on the neuromotor system in Alzheimer’s disease (AD) and natural
aging. Increased age is associated with muscle atrophy and weakness (sarcopenia) and is a significant predictor
of chronic disease and mortality in the elderly. Aging is a major risk factor for conditions such as AD and
obstructive sleep apnea (OSA). In the elderly population, pneumonia incidence is 3-times higher than in younger
age groups, with AD further increasing the incidence and severity of airway infections. The incidence of airway
infection in aging and age-associated disorders is undoubtedly related to sarcopenia of the diaphragm muscles
(DIAm) and discoordination of airway protective manoeuvres, which involve both DIAm and an assortment of
other respiratory-associated muscles including individual tongue, chest wall and abdominal muscles. This
proposal leverages the extensive experience of the PI in both respiratory neuromotor systems and
neurodegeneration. Previously, we found that DIAm sarcopenia was related to a loss of larger phrenic motor
neurons (MNs) and subsequent denervation, consistent with motor unit specific effects on maximum
transdiaphragmatic pressure generation. Our preliminary observations in both intrinsic and extrinsic tongue and
external abdominal oblique muscles also suggest sarcopenia in tongue may also be due to denervation.
Despite the cause of age-related MN loss being unknown, clues from neurodegenerative conditions that
affect MNs suggest that synaptic loss and mitochondrial disfunctions contribute to MN death, with
disproportionate effects on larger MNs. The major conceptual advancement in this proposal is to
comprehensively evaluate the entire motor unit: hypoglossal, thoracic and phrenic MNs – recruited to perform
motor tasks; neuromuscular junctions; and tongue, chest, abdominal and DIAm muscles. We hypothesize that
in old age and AD, motor impairments and loss of larger MNs (denervation) of respiratory muscles is underpinned
by MN and NMJ synapse loss and mitochondrial dysfunction (reduced volume density, fragmentation, and
activity). In addition, we will trial two approaches to ameliorate the contribution of synaptic loss (via SPG302) or
mitochondrial dysfunction (via edaravone) to MN death in AD and aging.
The proposed studies employ an array of innovative techniques, with assessments ranging from sub-cellular
through to system level behavior in Fischer 344 rats and in an AD model (TgF344-AD) on the same genetic
background. In Aim 1, we will assess excitatory and inhibitory synapse loss, dendritic and dendritic spine loss,
and survival of hypoglossal, thoracic and phrenic MNs. Additionally, we will evaluate denervation, sarcopenia
and functional impairments in tongue, chest, abdominal and DIAm muscles across aging and AD. In Aim 2, we
will assess mitochondrial volume density (MVD), fragmentation and function (SDHmax) in respiratory MNs and in
muscles in aging and AD. In Aim 3, we will assess whether mitigating synaptic dysfunction (by SPG302) and/or
mitochondrial dysfunction (by edaravone) improves outcomes in respiratory MNs and muscles in aging and AD.

Public health relevance
PROJECT NARRATIVE Respiratory dysfunctions (including those of the tongue, chest wall, abdominal diaphragm muscles) and increased incidence of airway infections are major contributors to morbidity and mortality in Alzheimer’s disease and aging. The exact mechanisms of how respiratory muscles are compromised with Alzheimer’s disease and aging is unknown, but likely involves all levels of the motor unit, the motor neuron pools in the brainstem and spinal cord and the skeletal muscle. This project will assess two major culprits in neural loss and muscle weakness at all levels of the motor system, investigating therapeutic strategies designed to mitigate the effects of synaptic dysfunction (SPG302) and mitochondrial disfunctions (edaravone).